Leveraging the HIF-alpha pathway to improve the engraftment and therapeutic efficacy of human nanowired cardiac organoids

PROJECT SUMMARY: Heart disease accounts for nearly 1 in 4 deaths in the United States each year,
highlighting the urgent need for therapies that can repair damaged hearts. Human induced pluripotent stem cell-
derived cardiomyocytes (hiPSC-CMs) have emerged as a powerful cell source for cardiac repair, but their
potential has been limited by poor survival and engraftment after injection. To address these challenges, our
lab has pioneered the development of nanowired human cardiac organoids composed of electrically conductive
silicon nanowires (e-SiNWs), hiPSC-CMs, and supporting cells. Our preliminary in vivo studies showed that
nanowired cardiac organoids successfully engraft in ischemia/reperfusion (I/R) injured rat hearts and develop
more organized contractile structures compared to non-nanowired cardiac organoids. Despite this progress, less
than half (~30%) of injected organoids remained engrafted in infarcted hearts 7 days post-transplantation, which
can be attributed to inadequate prevascularization and hypoxic/ischemic preconditioning of the organoids in vitro.
To address this, we have explored pharmacological stabilization of HIF-a as a strategy to promote
prevascularization and ischemic tolerance within the organoids. My preliminary in vitro data showed that
treatment with Molidustat, a prolyl hydroxylase domain (PHD) inhibitor, significantly improved endothelial network
and lumen formation (i.e., ~150% increase of CD31+ coverage) within the cardiac organoids. While these results
are promising, further investigation is necessary to reveal phenotypic and genotypic changes in HIF-α stabilized
cardiac organoids and how they correlate with transplantation efficiency. The goals of this proposal are to
determine the effects of HIF-α stabilization on vascular maturation, cardiac function, cell and tissue-level
metabolism, and transcriptomic changes in cardiac organoids (Aim 1), and to demonstrate therapeutic efficacy
of HIF-α stabilized organoids in a rat model of myocardial I/R injury (Aim 2). The central hypothesis of this
proposal is that stabilization of HIF-α signaling in cardiac organoids improves the survival and engraftment of
hiPSC-CMs in infarcted myocardium and enhances their capacity to promote cardiac functional recovery in
injured hearts. The proposal is innovative in that, for the first time, we will investigate how hypoxia mimetic
agents precondition human engineered cardiac tissue to enhance the transplantation efficiency of hiPSC-CMs.
My long-term goal is to develop clinically applicable cardiac regenerative therapies to treat cardiovascular
diseases. Accordingly, we will pursue the following specific aims: 1) Determine how pharmacological HIF-α
stabilization reprograms and preconditions human cardiac organoids for ischemic protection, and 2) Determine
the effects of HIF-α stabilization on graft-host anastomosis, long-term engraftment, and therapeutic efficacy of
nanowired human cardiac organoids in injured hearts. This research will inform emergent clinical applications
of hypoxia mimetic agents to treat cardiovascular disease and will help advance our human cardiac organoid
platform towards large animal studies to accelerate their clinical translation.

Public health relevance
PUBLIC HEALTH RELEVANCE: Cardiovascular disease is the leading cause of death worldwide. The goal of the proposed research is to use hypoxia mimetic agents to improve the transplantation efficiency and therapeutic efficacy of human induced pluripotent stem cell-derived cardiomyocytes (hiPSC-CMs) for treating cardiovascular disease.